Understanding critical transitions in chronic myeloid leukemia to improve tyrosine kinase inhibitor therapy

PROJECT SUMMARY/ABSTRACT
Chronic myeloid leukemia (CML) is a myeloproliferative neoplasm diagnosed in about 5,000 Americans
each year, characterized by the presence of the t(9;22) Philadelphia chromosome and its protein product, the
BCR-ABL1 tyrosine kinase, in the leukemic cells. Current therapy for CML is centered on tyrosine kinase
inhibitors (TKIs) such as imatinib mesylate, which can induce cytogenetic and molecular remissions in most
patients, who then enjoy normal age-adjusted life expectancy but usually require lifelong therapy. Despite this
clinical success, there are several unmet needs in CML research. One is to identify strategies to increase the
rate and depth of response to TKI therapy during the critical first year after diagnosis, when patients are most
vulnerable to disease progression. A related need is a better understanding of the mechanisms underlying
primary resistance to TKIs, to prospectively identify the ~10-15% of patients who will fail TKI therapy, and for
ways to overcome this resistance. Finally, there is a need to understand why some patients can stop TKI therapy
without relapsing despite the continued presence of low levels of malignant cells, and to develop rational
interventions to help more patients achieve so-called treatment-free remission, which is a surrogate for cure.
This Project seeks to address these unmet needs by continuing the application of systems biology
approaches to CML under the auspices of the UCI Center for Cancer Systems Biology (CaSB@UCI). In this
effort, a mathematical model of normal and CML myelopoiesis that incorporates feedback and feed-forward
interactions and recapitulates known features of CML biology and TKI response will be leveraged, in parallel with
a novel conditional transgenic bone marrow chimeric mouse model that accurately recapitulates early events in
the development of CML. In the first Aim, the cellular and molecular mechanisms of the non-mutational stochastic
process underlying a critical transition in CML development will be investigated by increasing the complexity of
the mathematical model based on experimental data to gain biological insight into mechanisms of this “tipping
point” in leukemogenesis. In parallel, studies in the mouse model (single cell transcriptomics, genome-wide
CRISPR screen, and spatial phenotypic analysis) will identify candidate molecules governing this transition,
which will then be tested directly using genetic approaches in mice in the second Aim. The third Aim will test
interventions in mice that are predicted to enhance TKI effectiveness, including targeting leukemic stem cell
proliferation and self-renewal, with the goal of translating these discoveries towards clinical application. The in
silico and in vivo approaches will be complementary, with predictions of the quantitative model tested in mice,
and results from mice informing the refinement of the mathematical model. The Project will also benefit from
interactions with the two other Projects in this P01 application, who seek to understand “tipping points” in solid
tumors through similar approaches and technologies. Results from this Project will yield important new
knowledge about the pathophysiology of CML and motivate new strategies to improve the therapy of this disease.

Public health relevance
PROJECT NARRATIVE Chronic myeloid leukemia (CML) is a type of blood cancer that is generally treated successfully with drugs, but some patients fail to respond, and most patients will require lifelong treatment with medications that are expensive and have substantial and even life-threatening side effects. This Project will make use of two new interactive models of CML, one based on mathematics and the other on mice, which have already generated new insights into the disease and its response to therapy. The long-term goal is to understand the mechanisms through which the leukemia develops, with a focus on identifying new strategies to improve treatment that can be moved towards clinical development.